Core 1: Human Cell Models of Aging Core

PROJECT SUMMARY – Human Cell Models of Aging Core
The SD-NSC Human Cell Models of Aging Core (Human Cell Core) is focused on creating new cellular models
of aging from human fibroblasts, including fibroblasts from a unique cohort representing the full breadth of adult
chronological age and annotated for physical and functional measures of biological age. Genetic model
organisms have long been important for aging research, but there are limitations to the extent to which animal
models faithfully represent the molecular and cellular process of human aging. The overarching goal of this
Core is to create powerful new human cell-based models to enable a wide range of studies into the molecular
and cellular heterogeneities of human aging. Approaches for generating these new human models of aging
draw largely from recent advances in creating induced cell types via the direct conversion of skin cell samples.
Pioneering work from the Human Cell Core co-Lead, Dr. Gage, has shown that aging characteristics are
maintained in these induced cell types. Pairing this approach with equally new approaches for creating 3D
organoid cell cultures representative of different organ and tissue microenvironments, enables the creation of
unprecedented human cell-based models of tissue aging. These models will enable robust analyses of cellular
heterogeneities in human aging processes. As part of this effort, the Core will recruit human subjects ranging in
age from 20–70+ years, thereby representing the full breadth of the healthy adult human age span. These
participants will be extensively phenotyped for key clinical and physiological features of biological aging, and
blood and skin samples will be collected. Skin samples will be used to derive primary dermal fibroblasts, from
which both reprogrammed stem cells and directly induced cell types will be created and banked for sharing.
The Human Cell Core will develop protocols for the direct inducement of different cell types and for the creation
of organoids, including pancreas, kidney, liver, heart, smooth muscle, and vasculature. To promote the uptake
of these new human cell models throughout the basic biology of aging research community, the Core will offer
workshops and training sessions in conjunction with the Research Development Core. The protocols, specific
reagents, and cells will be distributed to NSC affiliates directly from the Human Cell Core, and more broadly
through open resources and cell repositories like the NIA Aging Cell Repository at the Coriell Institute and
Addgene. Subject phenotype data will be shared along with the cell lines. Importantly, the Human Cell Core is
designed to be integrated with the other Research Resource Cores of the SD-NSC, as human cell models
(with subject-specific data) can be fed directly into the Heterogeneity of Aging Core for systems-level analysis
of aging processes (multi-omic and advanced imaging). These complex datasets can then be fed into the
Integrative Models of Aging Core for the application of new and existing integrative analyses. The Human Cell
Core, as a stand-alone resource, and as an integrated component of the SD-NSC Core pipeline, will create
substantial new opportunities to investigate the influences of cellular heterogeneity in human aging processes.